Ice-free vitrification and nano warming technology for banking of cardiovascular structures.

ABSTRACT
This diversity administrative supplement proposal is focused on obtaining postdoctoral support for an outstanding
individual, Dr. Fred Xavier, to work on our Phase II SBIR grant directed at translation of ice-free cryopreservation
by vitrification employing a novel approach of volumetric heating by nanowarming using Fe nanoparticles in an
alternating electromagnetic ﬁeld and be trained in small business entrepreneurship. Vitrification, sub-zero
storage below the glass transition temperature in a “glassy” rather than a crystalline frozen phase, is a form of
cryopreservation that avoids ice formation.
There are 3 specific aims in which we will employ porcine vascular models in a combination of ex vivo and in
vivo studies. Dr. Xavier will be involved in all three aims with emphasis on biomechanics, surgery, histopathology,
presentations, publications with training in all business aspects including customer outreach. His work will be
supervised by a multidisciplinary Advisory Oversight Committee consisting of faculty from Tissue Testing
Technologies LLC (T3LLC), Clemson University, Medical University of South Carolina, and Imperial College,
London, with Dr. Brockbank training him in business issues related to operating a small business.
In Aim 1 we will evaluate cryopreserved arteries after real time shipping, comparing methods and validating the
transport conditions that are finally approved based upon absence of tissue cracking. In Aim 2 we will
characterize the post-ice-free cryopreservation state of arteries preserved for at least 2 years. In addition, during
this aim we will characterize the chemistry and biomaterial properties of ice-free cryopreserved blood vessels.
In Aim 3 we will perform short-term transplant studies (28 days) in two porcine vascular models (femoral and
pulmonary artery into the carotid and pulmonary, respectively) in order to validate our technology for a future
Phase IIb SBIR proposal using clinically relevant preclinical non-human primate models and human tissues. At
the conclusion of these aims it is anticipated that Dr. Xavier will have the necessary tools to establish himself as
a successful independent clinical investigator and become an entrepreneur.

Public health relevance
NARRATIVE Our Phase II project is a great opportunity for Dr. Xavier to learn about small business opportunities because there are huge markets for research, diagnostic and clinical applications of our technology. Strategic assessment of the field has identified the need for better preservation methods because freezing methods of cryopreservation have been shown to damage tissues and organs due to ice formation. This proposal focuses on nanowarming technology development for cryopreservation by vitrification of large volume blood vessels samples. Nanowarming is required for viable, functional preservation of blood vessels. There are significant clinical needs for vascular grafts for dialysis as well as patients requiring peripheral and coronary bypass grafts. Advances in the preservation of tissues are also needed for trauma care, particularly to incorporate regenerative medicine products into strategic national stockpiles. This proposal combines the use of novel cryoprotectant formulations with magnetic nanoparticles and radiofrequency-induced warming to warm optimally vitrified, banked, living, biological materials. These technologies could eventually impact hundreds of thousands of patients in North America annually if applied to tissues, tissue engineered cellular constructs and one day organs.